UNC Center for AIDS Research Core B Developmental

PROJECT SUMMARY/ABSTRACT – DEVELOPMENTAL CORE (CORE B)
The Developmental Core (Dev Core, Core B) supports emerging and innovative work within the CFAR with
special emphasis on underrepresented minorities (URM) and international Early Stage Investigators (ESIs). Dev
Core will accomplish this through six overarching aims: providing mentoring services and Pilot Awards to support
our HIV/AIDS community; undertake new initiatives that build on and enhance the Core’s track record of
success; partner with other CFAR Cores, CFARs, and institutional programs to implement funding services and
mentoring supports; support CFAR Scientific Working Groups and Research Interest Groups through training
and mentoring opportunities; conduct strategic planning, dissemination, outreach and evaluation to assure
effectiveness the Core’s functioning; and conduct the Core’s work in alignment with CFAR standardized policies
and procedures. To achieve these aims the Dev Core provides a range of services, foremost of which is funding
supports in the form of competitive mentored Pilot Awards (12 months, up to $40,000) aligned with NIH HIV
research priorities targeted to ESIs and senior investigators new to HIV. This includes researchers affiliated with
the CFAR institutions (UNC-CH, FHI 360, RTI), North Carolina Historically Black Colleges and Universities (NC
HBCU), and international investigators with a strong connection to the CFAR. The Core also provides
microgrants (up to $5000) to support ESI achievement of research outcomes such as data analysis to strengthen
NIH funding applications or research dissemination; Pilot Award supplements ($10,000) for research aligned
with SWG priorities; and funding for a Summer HBCU & URM Fellowship to provide protected research time for
HBCU ESI faculty. The Core ensures that all Pilot Awards and CFAR Administrative Supplements have
appropriate regulatory and NIH approvals and monitors progress toward publication and funding outcomes for
the same. ESI mentoring and training supports are provided through one-on-one interactions as well as peerbased mechanisms including a Developmental Cohort open to all ESI with a UNC CFAR affiliation, and an
HBCU Cohort to address context-specific needs. The Dev Core provides structured resources such as
orientation meetings and resource data bases for mentors, Awardees, and Cohort members and partners with
other CFAR Cores to support the Pilot Award program through mentoring, proposal reviews, and access to
reduced fee or free Core services. The Core further leverages other developmental programs such as the UNC
CTSA and inter-CFAR resources such as the UCSF mentoring-the-mentors program to efficiently achieve Dev
Core goals. The Core effectively uses a broad range of tools for communicating with and serving the Dev Core’s
geographically dispersed user base, including on-line meetings, webinars, on-site meetings, and the CFAR’s
online resources and listserv. The work of the Core will be guided by consultation with the Administrative Core,
other CFAR Core Directors, surveys of the CFAR membership, an Internal Advisory Board, and an External
Advisory Board.